Family Listening Program (FLP) Culturally-Centered Dissemination & Implementation Project

Program Director/Principal Investigator (Last, First, Middle): Belone, Lorenda Abstract The goal of this application is to strengthen dissemination and implementation (D&I) science by testing the implementation of our indigenous focused Family Listening Program (FLP), which is a culturally transformed intervention through the use of a community-based participatory research (CBPR) approach. FLP is currently undergoing a rigorous R01 examination with three distinct southwest tribal communities (Jemez Pueblo, Ramah Navajo, & Mescalero Apache), who have established their own active Tribal Research Teams (TRTs). In this new study we introduce an innovative process called CBPR Culture-Centered System which will be integrated with the Interactive Systems Framework (D&I structures and functions to bridge science & practice) for an examination of the uptake, cultural acceptance, and sustainability of evidence-based strategies moved into practice with three new southwest tribal communities, Torreon-Star Lake, Nahata Dziil, and Zia Pueblo, who will each develop their own research community advisory board (CAB). This grant will continue the long- term research partnership with the current R01 TRT partners that provides a solid foundation for collaborating on the synthesis and translation of the following tools that will facilitate the three new CAB partners to adapt their own FLP curriculum and evaluation measures into their own distinct cultural knowledge, histories, values, and practices for implementation: a) Quality Implementation Tool; b) CAB Development Guide; c) Culture- Centered Coaching Guide; d) Digital Story Modules; and e) Culture-Centered FLP Toolkit. Preliminary findings have shown FLP's early effectiveness in reduced child depression, anxiety, and enhanced protective factors of cultural connectedness and coping skills. In this application, the University of New Mexico (UNM) College of Education with the UNM Center for Participatory Research and our TRT partners will provide a support system to the CABs in the cultural-recentering and implementation of their own FLP program in which the delivery system will be rigorously evaluated. The FLP is perfectly poised to take the next step of D&I and this study will facilitate bi-directional knowledge translation between academic and tribal partners while utilizing a CBPR Culture-Centered System (CCS) an innovation that represents the intersection of academic and tribal spheres of influence and knowledge to create a novel implementation approach. This study has three specific aims: 1) With TRT partners, “synthesize and translate” previous R01 research findings into pre-implementation steps with three new tribes, i.e., build new Community Advisory Boards (CABs); assess contextual facilitators and barriers, and re-center FLP curricula into new cultures for sustainability; 2) Test a bi-directional coaching “support system” with UNM and the TRTs providing technical assistance and trainings to new CABs; and producing, as co-learners, digital stories for the final CBPR CCS Guide; and 3) Evaluate the capacity of the “delivery system” of the CABs to implement the practice- based FLP Toolkit (curriculum and program evaluation tool), re-centered into their cultural knowledge and context.

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Belone, Lorenda Project Narrative This study will strengthen dissemination and implementation (D&I) science by testing the implementation of our indigenous focused Family Listening Program (FLP), which is a culturally transformed intervention through the application of a community-based participatory research (CBPR) approach. In this new study we introduce an innovative process called CBPR Culture-Centered System which will be integrated with the Interactive Systems Framework (D&I structures and functions to bridge science & practice) for an examination of the uptake, cultural acceptance, and sustainability of evidence-based strategies moved into practice with three new southwest tribal communities. This grant will continue its long-term CBPR partnership with three southwest tribal partners which will provide a solid foundation for collaborating on the synthesis and translation of the following tools that will facilitate three new southwest tribal partners to adapt their own FLP curriculum and evaluation measures into their own distinct cultural knowledge, histories, values, and practices for implementation: a) Quality Implementation Tool; b) CAB Development Guide; c) Culture- Centered Coaching Guide; d) Digital Story Modules; and e) Culture-Centered FLP Toolkit.